Core--Biostatistics and data management

DESCRIPTION (provided by the applicant): Specific Aims: To provide design expertise, data entry, management, and analysis support for the five projects comprising this Program Project. To orchestrate and help design collaborative projects between the UT Stroke Center and other Stroke Centers in SPOTRIAS, in particular multicenter trials of acute stroke therapy. To provide an educational resource for stroke trainees interested in clinical trial methodology.